State-dependent connectivity of impaired autonomic brain networks underlying cardiorespiratory dysfunction in epilepsy

PROJECT SUMMARY/ABSTRACT
Sudden unexpected death in epilepsy (SUDEP) accounts for up to 18% of all deaths in epilepsy and up to 50%
of all deaths in drug-resistant epilepsy. The strongest clinical risk factor for SUDEP is ongoing tonic-clonic
seizures (TCS), and failure of cardiorespiratory function during TCS has been implicated as a major cause of
SUDEP. Patients with temporal lobe epilepsy (TLE) experience cardiorespiratory and autonomic abnormalities
both interictally (between seizures) and ictally (during seizures). These abnormalities have been related to
elevated risk for SUDEP and include central apnea during the peri-ictal period and increased cardiac
sympathetic modulation during the interictal and peri-ictal periods. However, the neural mechanisms underlying
cardiorespiratory deficits in epilepsy and their relationship to SUDEP are largely unknown. Preliminary
evidence from animal and human studies suggests that cardiorespiratory dysfunction in epilepsy may be linked
to seizure-related disruptions of neural circuits involved in cardiorespiratory and autonomic regulation. In this
proposal, we aim to integrate multimodal neuroimaging and electrophysiological data with measurements of
cardiorespiratory activity to investigate impaired autonomic brain networks in TLE during the interictal state
(Aim 1) and peri-ictal state (Aim 2). Currently, it is unknown how brain network disturbances directly impact
cardiorespiratory and autonomic function. Cardiorespiratory activity is not commonly recorded in epilepsy
monitoring units or neuroimaging research. We hypothesize that studying dynamic interactions between the
central autonomic network and cardiorespiratory activity will reveal neural circuit impairments associated with
interictal and ictal cardiorespiratory deficits. In Aim 1, we will analyze simultaneous functional MRI (fMRI),
cardiac, and respiratory data to identify cardiorespiratory coupled brain connectivity abnormalities of the central
autonomic network in TLE that are related to SUDEP risk factors such as recurrent TCS. This aim will uncover
chronic alterations of autonomic circuits that may predispose TLE patients to severe cardiorespiratory
dysfunction and SUDEP. We will also leverage advanced preprocessing methods to investigate subcortical
autonomic centers that have been under-examined in prior fMRI studies of SUDEP. In Aim 2, we will analyze
concurrent stereo-electroencephalography (SEEG) and respiratory data to identify abnormal neural-respiratory
coupling and brain connectivity in cortical autonomic regions during temporal lobe seizures with ictal central
apnea. This aim will elucidate seizure-induced impairments in respiratory-related neural communication that
may serve as a biomarker of ictal apnea. Previous studies have associated ictal apnea occurrence with seizure
spread to the amygdala. Here, we hypothesize that that ictal apnea results from transient disruptions of a wider
network of brain regions involved in voluntary and autonomic control of respiration. If successful, the proposed
aims can guide discovery of novel neural biomarkers of SUDEP risk and cardiorespiratory dysfunction,
improving risk stratification and identifying neuromodulation targets for preventive treatment.

Public health relevance
PROJECT NARRATIVE Patients with temporal lobe epilepsy experience deficits of cardiorespiratory and autonomic function, which have been linked to elevated risk for sudden unexpected death in epilepsy (SUDEP). This study aims to integrate functional brain imaging and electrophysiological data with measurements of cardiorespiratory activity to characterize brain network impairments contributing to cardiorespiratory dysfunction in temporal lobe epilepsy. The results of this work can help improve identification of patients at risk for SUDEP and can aid in discovering brain targets for preventive treatment.